Mechanism of Meissner corpuscle function

Somatosensation is essential for everyday life. Many vertebrates, including humans, use the sense of touch to
navigate in the environment, manipulate tools and objects, find food and perform various mechanical tasks. Key
to this ability are somatosensory corpuscles located in the skin. In this proposal, we focus on Meissner
corpuscles, which are essential for performing fine tactile tasks due to their ability to detect transient mechanical
stimuli. Despite their importance for somatosensation, the mechanism of Meissner corpuscle function is
unknown. Meissner corpuscles are located in the skin of many vertebrates, and consist of lamellar cells in contact
with a neuronal mechanoreceptor. The mechanoreceptor is thought to be the key sensory element within the
corpuscle, whereas the function of lamellar cells is unknown. In this proposal, we will functionally test the
hypothesis that Meissner lamellar cells are active detectors of touch. To do this, we will use bill skin of tactile
specialist ducks, which contains a high density of Meissner corpuscles accessible for experimental
manipulations. We will investigate the molecular mechanism of touch sensitivity in Meissner lamellar cells, study
their interaction with neuronal mechanoreceptor, and investigate their role in somatosensory physiology. We will
employ an integrative approach, including neurophysiology, biophysics and imaging. Results from this basic
scientific proposal will provide mechanistic insights into the process of somatosensation in vertebrate skin.

Public health relevance
The sense for touch is essential for navigation in the environment, manipulation of tools and objects, foraging, detection of physical pain, development of social behaviors. Despite its fundamental importance for physiology, many molecular and physiological aspects of the sense of touch are poorly understood. The goal of this proposal is to unravel the mechanism of touch detection by the specialized end-organs in the skin of vertebrate called Meissner corpuscles. Results from this study will provide general scientific knowledge which will contribute to the development of pharmacological tools to alleviate somatosensory disorders associated with hypersensitivity to touch in humans.